EVALUATION OF CENTRAL VENOUS CATHETER

This study has two objectives. The first is to compare the incidence and severity of complications occurring with the use of "Broviac" vs "Per Q Cath" central venous lines in the NBICU. The second objective is to determine the frequency of colonization of various catheter sites in order to suggest a means by which catheter-related sepsis may be reduced.